A somatic hypermutation defective UNG mutant in antibody deficiency through destabilization of RPA interaction.

PROJECT SUMMARY:
B cells require somatic hypermutation (SHM) and class switch recombination (CSR) to develop high affinity,
isotype switched immunoglobulins (Igs). Human patients deficient in these processes suffer from hyper IgM
syndrome, a primary immunodeficiency characterized by recurrent and severe infections. They have low IgG
levels and are often unable to develop high-affinity antibodies. Both CSR and SHM are initiated by activation-
induced cytidine deaminase (AID) which deaminates cytidines, creating uracils in Ig genes. Uracil is removed
by Uracil DNA glycosylase (UNG) and repaired in an error-prone fashion to complete SHM and CSR. UNG is
normally associated with high-fidelity base excision repair. The mechanism that directs uracil removal to error-
prone repair during SHM is not understood. However, mis regulation could threaten genome integrity through
inappropriate mutation or suppress SHM and the generation of high-affinity antibodies. To determine if UNG
directly influences repair outcome, we analyzed various mutants of UNG in cell-line, AID induced mutation
reporter assay. We found that UNG with point mutations in the Replication Protein (RPA) binding domain
efficiently supported high-fidelity repair, while suppressing the frequency of mutation. Furthermore ,RPA
mutants unable to interact with UNG also suppressed mutation frequency. Our hypothesis is that UNG-RPA
interaction governs error-prone repair during SHM in B cells. The cell line models available do not completely
recapitulate B cell SHM in terms of frequency and mutational spectrum. Therefore, our objective is to create a
mouse model with a UNG mutant deficient in RPA binding to investigate error-prone repair. We will accomplish
this in Aim 1 by using CRISPR gene editing technology to create a mouse with mutant UNG. In Aim2 this
mouse will be used to define how UNG-RPA interaction in B cells results in SHM. We expect with the
completion of these goals to have a mouse model deficient in normal SHM and a system to mechanistically
investigate how UNG and RPA regulate error-free or mutation repair outcome during base excision repair of
uracils.

Public health relevance
PROJECT NARRATIVE: Somatic hypermutation (SHM) is essential for B cells to evolve high-affinity antibodies against pathogens and vaccine immunogens and deficit SHM is associated with human immunodeficiencies. We find that Uracil-DNA glycosylase (UNG) mutants unable to interact with replication protein A (RPA) impair mutation events in vitro. The goal of this application is to develop a mouse model to understand the mechanistic contribution of RPA- UNG interaction to SHM in vivo.